Bioinformatics and Biostatistics Data Analysis Core

ABSTRACT
The Biostatistics and Computational Genomics Core will provide support in statistical and
computational analysis of sequencing data, biomarker development and validation, pre-clinical
study design and analysis to meet the needs of the SPORE Research Projects and interact with
other Cores and institutional resources to achieve the scientific and translational purposes of the
SPORE. The Research Projects in this SPORE require a broad range of statistical and
bioinformatics expertise, including tools for the analysis and visualization of whole genome
sequencing and single cell sequencing data. The Core will provide a team of dedicated
personnel with extensive experience and strong track record of developing innovative statistical
and computational methods. We will maintain and expand current tools and pipelines to assist
the design and analysis of the SPORE research projects, and provide centralized support for
data collection, processing, quality assessment, and normalization procedures to facilitate data
integration and downstream analysis and visualization. Importantly, the core will devote
significant effort in developing innovative computational tools that aim to detect, quantify, and
track genomic signatures of specific DNA repair defects and/or genetic instability at the tumor
bulk and single cell levels. In addition, the Core will synergize with the current infrastructure
available at Memorial Sloan Kettering Cancer Center to provide the SPORE investigators not
only with the state-of-the-art computational biology methods, but also with novel computational
tools to address specific analytical challenges germane to the success of the SPORE Research
Projects.

Public health relevance
NARRATIVE The overall goal of the Biostatistics and Computational Genomics Core is to ensure streamlined and customized services, support, and innovation in data processing, analysis, storage, and visualization; the design of laboratory experiments and validation; the design and analysis of prospective cohort studies and clinical trials, and to assist the SPORE investigators in the achievement of their scientific and translational goals of the research projects.